Protein aggregation controlled by disaggregases.

Project Summary
Our lab aims to deepen the understanding of the molecules and mechanisms that drive protein
aggregation. We approach this by studying protein aggregation catalysis and inhibition through
biological disaggregases, including macromolecular chaperones, proteasomes, and metabolites.
Our recent findings suggest that disaggregase activity operates on a continuum, with protein
aggregation catalysis and inhibition at opposite ends of the spectrum. Bimodal effects on protein
aggregation are a defining characteristic of disaggregases. The disaggregase mechanism,
characteristic of macromolecular chaperones, generates fragmented fibrils, oligomers, and
monomeric proteins in varying proportions, which seed protein aggregation. Although seeding is
primarily associated with disease, bimodal effects by disaggregases on seeding suggests
disaggregases might toggle aggregation, regulating protein activity by switching it on and off
depending on concentrations and relevant cofactors. However, the extent to which the same
disaggregases can function both as inhibitors and aggregation catalysts under different conditions
to regulate protein activity remains unclear. Our lab will explore the biological implications of
disaggregases in reversibly regulating protein function. We hypothesize that disaggregases
generating intermediate species, such as oligomers and fragmented fibrils, promote aggregation
by creating seeding-competent nuclei, which inactivate proteins by sequestering them in
aggregates. We anticipate that shifting disaggregase concentrations to favor aggregate
elimination will restore the activity of functional proteins. Our future objectives include
bioinformatic, biochemical, and cellular studies to uncover the molecular determinants of
disaggregase activity and identify new biological disaggregases in the human metabolome. By
elucidating the factors involved in both protein aggregation catalysis and disaggregase efficacy,
our work will reveal disaggregases that can reversibly control protein aggregation. This
foundational research will guide our lab’s ongoing efforts to unravel the etiology of protein
misfolding and develop diagnostics and therapeutics for protein aggregation diseases.

Public health relevance
Project Narrative Our lab focuses on uncovering the molecular mechanisms that drive protein aggregation, a process often linked to disease. We investigate how biomolecules like chaperones, proteasomes, and metabolites either catalyze aggregation or disaggregate fibrils, with a particular focus on disaggregases. We anticipate that disaggregases regulate protein activity by toggling between aggregation and disaggregation, and our studies explore how this dynamic goes awry leading to protein misfolding diseases.